Pelvic Floor Disorders Network Clinical Site

Project Abstract
This application to be a Pelvic Floor Disorders Network Clinical Site contains both an innovative
randomized controlled trial and comprehensive description of Northwestern Medicine’s unique
strengths, as a team and environment, to contribute to all PFDN trials. Our concept proposal draws on the
collective experience of our team in exercise physiology, perioperative optimization, and postoperative recovery.
The proposal describes a randomized controlled trial of prescriptive early exercise following prolapse surgery to
reduce deconditioning and improve recovery without any negative impact on pelvic floor outcomes. Our
proposed study will go beyond existent research and be the first to implement and quantitatively
evaluate (using accelerometer data) a postoperative exercise regimen and its effects on recovery and
pelvic floor symptoms. In addition, our proposal highlights the strengths of our large, high volume, multi-
disciplinary team, which draws from a diverse patient population across several regional hospitals to ensure
equity and inclusion within PFDN clinical trials. We can also leverage our resources and collaborations as part
of two NIDDK cooperative networks related to urinary incontinence and bladder health to advance the PFDN’s
goals. The NM team is a nationally recognized group of collaborative, productive, and established
investigators well poised to lead the design, implementation, analysis and dissemination of this
multicenter RCT as well as participate in and lead additional studies within the PFDN.

Public health relevance
Project Narrative We propose an innovative randomized controlled trial of prescriptive early exercise following pelvic organ prolapse surgery to help reduce the time to full recovery without impacting pelvic floor outcomes. With this study, we hope to drive the needle forward on the perioperative care of women undergoing minimally invasive surgery. This has the potential to transform care for women with prolapse who will no longer be required to alter their lifestyle and the activities for which they are having surgery.